Mutual communications between RhoA signaling and P4 signaling in luteal cells and the uterus during early pregnancy

Project Summary / Abstract
Embryo implantation is an essential step for mammalian pregnancy. It requires timely mutual communication
between a competent embryo and a transiently receptive uterus, in which progesterone (P4) and P4 receptor
(PR) play an essential role. The first physical embryo-maternal interaction is established between trophoblasts
and uterine luminal epithelial (LE) cells during embryo attachment for implantation initiation (~day 4.0 post-coitum
(D4.0) in mice). How the LE senses the embryo remains largely unknown. RhoA is one of the most highly
expressed genes in D3.5 and D4.5 mouse LE. RhoA is a GTPase with mechanosensing function. It is detected
intensely in the apical membrane of D3.5 LE, the initial contact of an implanting embryo, and luteal cells, the site
of P4 production during early pregnancy. RhoA uterine conditional knockout RhoAf/fPgrCre/+ (RhoAd/d) mice have
P4 deficiency with diminished expression of StAR (the rate-limiting protein for P4 synthesis) in the luteal cells
and embryo implantation failure. Exogenous P4 treatment upregulated StAR expression in the RhoAd/d luteal
cells and partially rescued embryo implantation in the RhoAd/d mice, indicating that RhoA regulates P4 production
and P4 can partially compensate for luteal cell StAR-deficiency and embryo implantation failure in the RhoAd/d
mice. The mechanisms for P4-RhoA crosstalk remain unknown. To circumvent P4 deficiency in RhoAd/d mice, I
ovariectomized RhoAf/f (control) and RhoAd/d mice and treated them with vehicle, P4, E2, or E2 + P4 for 24 hours.
Masson’s Trichrome staining reveals altered responses to P4 in the ovariectomized RhoAd/d uterus. Based on
literature and my preliminary data, I hypothesize that RhoA signaling and P4-PR signaling crosstalk in luteal cells
and uterine endometrium to regulate embryo implantation. This hypothesis is being tested in two Specific Aims
to determine mutual regulations of RhoA signaling and P4-PR signaling in the luteal cells for P4 synthesis (Aim
1) and in the uterus for establishing uterine receptivity (Aim 2), respectively. RhoAd/d in vivo mouse model, in
vitro models of luteinized human granulosa-lutein cells and human uterine epithelial (UE) organoids coupled with
3D microfluidic female reproductive system (FRT)-on-a-chip, as well as pharmacological approaches will be
employed. The successful completion of the ongoing and proposed studies in my F31 application will provide a
comprehensive picture of interplays between two important signaling pathways, RhoA signaling and P4-PR
signaling, in the luteal cells and uterine cells in regulating early pregnancy. It will also give insights into potential
therapeutic targets to treat infertility and early pregnancy loss due to ovarian and uterine dysregulation. The
fellowship training will take place at the University of Georgia in Dr. Xiaoqin Ye’s lab, which has the suitable
environment (e.g., expertise, funding, equipment, etc.) for personal and professional growth. The training plan
will also include dissemination of research at conferences and via publications to build my presentation skills,
weekly reports and lab meeting presentations to improve my time and project management skills, as well as
training for mentoring and leadership skills to foster my development as a well-rounded scientist.

Public health relevance
Project Narrative The proposed research is relevant to public health as successful luteinization and subsequent progesterone signaling are the rate limiting steps for both proper ovulation and establishment of uterine receptivity for embryo implantation. This proposal aims to investigate the mutual mechanisms of small GTPase RhoA, which is expressed across the female reproductive system, and progesterone and its receptor in the ovarian and uterine environments to characterize crosstalk during early pregnancy. Initial characterization of RhoA and progesterone interactions in a murine model will provide preliminary data for justification of further studies in humans, especially for women suffering from infertility or endometriosis.